PHARMACOKINETICS OF PHYSOSTIGMINE IN PATIENTS WITH ALZHIEMERS DIS.

This study involved the evaluation of the disposition of physostigmine in 10 patients with Alzheimer's Disease. Serial blood sampling was carried out for 90 minutes after a 2 mg oral dose of physostigmine salicylate. Samples were collected, stored and quantitated using a method previously documented in our laboratory. No detectable plasma levels were evident in two of the patients in the study. The other eight patients had a mean maximum concentration of 1.35 ng/ml (range 0.67 -2.4). No adverse effects were seen at the 2 mg dose. This data will be helpful in adjusting the dose to appropriately determine whether the drug is efficacious.